Population Research

The Population Research Core (PopRC) is a centralized resource dedicated to the needs of the Holden
Comprehensive Cancer Center (HCCC) in the domain of population science. Quality epidemiology support
promotes strong observational study designs and data collection and data curation methods. The primary
resources of the PopRC are its scientific personnel and its curated and annotated population-based data. The
PopRC provides HCCC members with guidance and assistance in accessing and using large databases of
cancer patient data that include SEER- Medicare, SEER-Medicare Health Outcomes Study (MHOS), enhanced
unlinked SEER research dataset, Iowa driver's license database, the Iowa Mortality database, the Greater
Plains Collaborative, and others. A number of these resources are unique to the HCCC catchment area (the
state of Iowa). In addition to database research activities, the PopRC supports personnel with a wide range of
expertise including population study designs, field research methods and tools, and biospecimens linked to
clinical registries. PopRC personnel collaborate closely with the Biostatistics Core on analytic plans and data
analysis of population studies, and with the Biospecimen Procurement and Molecular Epidemiology Resource
(BioMER) to ensure efficient and effective coordinated access for investigators to biospecimens. The PopRC
collaborates with the BioMER by providing samples from the Iowa Residual Tissue Repository and Virtual
Tissue Repository that are linked to SEER data. The PopRC supports HCCC members from all four research
programs. Projects commonly involve collaborations of HCCC epidemiologists with clinician and basic
scientists across the HCCC and from other academic institutions. The PopRC is a comprehensive,
collaborative and integrated resource that is vital to the HCCC.

Public health relevance
PROJECT NARRATIVE Not applicable